CHILD HEALTH RESEARCH CENTER

This is an application for the establishment of a Center of Excellence in Child Health at Washington University School of Medicine. The scientific focus of our Center is to develop and utilize genetic models of human disease states in transgenic and knockout mice. The long-term goal of our Center is to develop Scholars in human developmental biology. We shall achieve this goal by applying the recent advances in cell, molecular and developmental biology to an understanding of the pathogenesis and treatment of a broad spectrum of diseases within the Pediatric arena. In order to accomplish this we shall combine the established areas of investigative strength of Washington University School of Medicine and its Department of Pediatrics with basic and applied developmental biology. The establishment of the proposed Scholar's program will close the gap between basic developmental biologist and pediatric clinician. We shall provide a structure in which bright, motivated, young pediatric scientists will flourish in a protected environment as to emerge as leaders in an evolving area of Pediatrics. Alan L. Schwartz, Ph.D., M.D. will serve as Program Director and P.I. The Center (via this award and matched funds from Washington University School of Medicine) will establish a core facility for the generation of animal models of human disease states via new and evolving state-of-the-art technologies. The long-term goals of the Center will be realized as its Scholars contribute to the development of and leadership in human developmental biology during the next two or more decades.